Deep South KUH Premier Research - Interdisciplinary Mentored Education (PRIME) Training Core

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The overall mission of the Deep South KUH PRIME TL1 Training Core is to provide training in interdisciplinary and translational research that ensures pre- and post-doctoral trainees will learn the skills and knowledge to successfully transition to the next steps of their careers in KUH research. To overcome the challenge presented by a lack of researchers adequately trained in basic, clinical and population sciences, we will develop an integrated training program that focuses on interdisciplinary and translational research with support from experienced mentors and enhanced collaboration. The impact of our program will be felt across the Deep South through established strong partnerships between Augusta University, Tulane University and UAB. The TL1 Core is designed to support highly talented trainees from a wide range of scientific backgrounds. This includes trainees from nephrology, urology, urogynecology, and non-malignant hematology as well as relevant disciplines in pediatrics, surgery, medicine, epidemiology, and biomedical engineering among others. There will be no specific restrictions to joining the TL1 program across disciplines provided the research is relevant to the KUH goals. While we will leverage successful approaches developed for current T32 and related programs and other institutional resources, this new program will broaden the spectrum of research training to include those not directly funded by the TL1. We will work closely and collaboratively with the U2C Administrative, Professional Development and Networking Cores to assume a seamless process for developing skills that will be critical for achieving success in the modern workforce. The TL1 Core will work with each trainee on an individual basis to ensure appropriate mentoring, research opportunities and educational experiences to meet their personal and professional goals. Further training will include developing skills in managing and leading research teams critical for future success in KUH research. This effort will encompass the spectrum of trainees supported by the TL1, institutional trainees supported by extramural awards (R25s, Fs, Ks, CDAs etc.) or other mechanisms (graduate, medical, and public health schools, residency programs, and basic & clinical fellowship programs). The TL1 Core has three specific aims: 1: Establish didactic training and instructional programs to expand the knowledge base and interest in scientific discovery of pre- and post-doctoral trainees in the areas related to kidney and non-malignant diseases of the upper and lower urologic and hematologic systems, 2: Develop individual training plans that include instilling a culture of discovery supported by interdisciplinary, translational activities designed to meet individual interests, needs, and goals, and 3: Collaborate with the Administrative, Professional Development, and Network Cores to achieve the following mission-oriented objectives. These include programs to recruit and retain individuals from various disciplines, evaluate and support the training program, personalize research training with writing, presentation and leadership skills, and foster a larger network of mentors, collaborators and peers to engage the broader scientific community.

Public health relevance
We have not made any modifications to our goals relevant to public health. A larger, better trained workforce focusing on kidney, urological, and hematological disease is a critical need for public health in our region and the US in general.